2025 Muscle: Excitation-Contraction Coupling Gordon Research Conference and Seminar

Summary
This proposal seeks partial support for the Gordon Research Conference (GRC) on Muscle Excitation-
Contraction coupling (ECC). This international conference has been a central hub for tremendous progress in
this important field. The latest advances in skeletal, cardiac, and smooth muscle ECC will be investigated at
different levels (from biophysics, imaging, electrical and calcium-dependent signaling, to integrated function) to
garner insight into normal physiological function, dysfunction in disease, and potential therapeutics. This GRC
will meet June 1-6, 2025 at the Rey Don Jaime Grand Hotel near Barcelona, Spain. The program was developed
in consultation with a broad advisory group of leaders in ECC research. This group and the GRC are chaired by
Drs. Montserrat Samsó (USA) and László Csernoch (Hungary). Support is also sought for an associated Gordon
Research Seminar (GRS) that is led by and focused upon early-stage investigators (ESIs; students, postdocs,
and new faculty). This GRS immediately precedes the GRC and is chaired by two ESIs (Dr. Callum Quinn from
the UK, and Dr. Christopher Ko from the USA). The GRC and GRS endeavor to create a forum for young and
established researchers working in the most diverse fields of muscle research, where they can share their latest
results, participate in discussions held in a stimulating environment and lay the foundations for collaborations.
To this end, a program has been carefully constructed that discusses the function of the skeletal, heart, and
smooth muscles in a broad sense, from the structure of molecules important in muscle function, to the further
clarification of the role of sub-cellular organelles in the understanding of pathological processes. The application
of novel high-throughput techniques and the use of artificial intelligence (AI) in studying muscle function, helping
to solve muscle related diseases, will also be discussed. The conference aims to pay special attention to
motivating junior ECC ESIs to continue and complete their research careers by providing an interactive informal
forum for presenting their work and promoting networking. The 2025 ECC GRC will have 38 speakers, 6 shorter
talks to highlight selected posters, and 9 topic discussion leaders. Scientific sessions will detail the structure-
function of ECC at multiple scales ranging from the molecular level to translation into new therapeutic strategies
for ECC-related diseases. Sessions include, 1) muscle ultrastructure, 2) key regulatory proteins, 3)
mechanosensation, 4) atrophy, regeneration and aging, 5) specialized surface membrane structures, 6)
intracellular organelles, 7) high throughput approaches and AI, 8) new therapies for myopathies, and 9) a keynote
session. The GRS will help ESIs develop self-confidence and encourage full engagement in formal and informal
discussions with senior colleagues. The GRC will highlight ESI presentations in several ways (short talks, Poster
Flash talks, and participation as discussion co-leaders). We expect to attract ~175 basic and clinical researchers
across career stages, genders, races, heritages, research disciplines, institutions, and geographical locations.

Public health relevance
NARRATIVE The 2025 Muscle: Excitation-Contraction Coupling Gordon Research Conference will further our understanding of the physiology of skeletal, cardiac, and smooth muscle, and the mechanisms leading to the development of their dysfunction, and thus help to develop novel therapeutic approaches for the treatment of various clinically important disorders, which pose a significant burden for society. GRC is the leading international conference where students, young investigators, and early career researchers present their latest results, meet prominent scientists within the field, and lay the foundations for long-term collaborations. This GRC is the forum where all experts of this research area meet and as such is fundamental for the development of this vibrant scientific field.